The tale of two pandemics: Understanding racial and ethnic disparities from the collision of HIV and COVID-19 in the U.S.

PROJECT SUMMARY
The collision of the COVID-19 pandemic with the existing HIV epidemic in the U.S. has exacerbated the decades
old racial/ethnic disparities in HIV. For example, Blacks account for 42-44% of HIV diagnoses and deaths among
people living with HIV (PLWH) while accounting for only 12% of the population. These racialized disparities in
the U.S. HIV epidemic are further compounded by the same disparities emerging in COVID-19. We have shown
that PLWH appear to be at higher risk of poorer COVID-19 outcomes than persons not living with HIV (PNLWH),
and that the odds of incident COVID-19 infection among PLWH are 60% and 118% higher among Black and
Latinx persons, respectively, than whites. These racialized disparities are likely largely driven by social
determinants of health (SDoH) underlying our health systems—an understanding of the SDoH pathways that
elucidate these disparities is urgently needed to develop the next generation of HIV interventions operating at
the structural and social levels, and ever more now in the context of COVID-19.
The National COVID Cohort Collaborative (N3C) leverages real-world, national data and presents an
unprecedented opportunity to inform the NIH priority aims to understand the social and biologic factors that may
affect both HIV and COVID-19 outcomes. N3C is the largest electronic health record (EHR) repository in U.S.
history (>10M patients), contains both unparalleled individual-level granular clinical and historical data, and
represents the largest U.S. cohort of PLWH with their HIV and COVID-19 outcomes data (>77K), allowing
us to evaluate the bi-directional impact of existing HIV infection and COVID-19 outcomes. Furthermore,
individual-level data in the N3C are uniquely positioned to merge publicly available datasets that measure area-
level SDoH. Our central hypothesis is that the observed racial/ethnic disparities in HIV and COVID-19 occur in
a larger context of individuals embedded in social, political, and economic contexts, i.e., SDoH. Understanding
these forces, centered on SDoH, allows us to determine the next generation of HIV interventions.
Our three aims respond to the NIH call using data science, rigorous machine and statistical learning, and
multi-level mediation and epidemic modeling. The goal of Aim 1 (HIV outcomes) is to identify multilevel, social
determinants of racial/ethnic disparities in HIV outcomes (e.g., viral suppression [VS] and hospitalization) during
the COVID-19 pandemic. The goal of Aim 2 (COVID outcomes) is to understand the independent and
aggregated impact of SDoH and clinical characteristics on HIV immune dysfunction for COVID-19 outcomes and
vaccine effectiveness (2a) and quantify the differential impact of HIV on COVID-19 outcomes at the U.S.
population level by race/ethnicity (2b). The goal of Aim 3 (HIV epidemic modeling) is to quantify the impact of
the COVID-19 pandemic on HIV treatment (VS and hospitalization) and prevention (pre-exposure prophylaxis
[PrEP] use and HIV/sexually transmitted infections [STI] testing frequency) outcomes by race/ethnicity at the
population-level for the national Ending the HIV Epidemic (EHE) initiative’s priority jurisdictions.

Public health relevance
PROJECT NARRATIVE This research will contribute to public health efforts to improve treatment and prevention outcomes for people living with or at risk for HIV in U.S., especially those belonging to racial/ethnic minority communities. Findings from this study will have important implications for HIV treatment and prevention approaches for the COVID-19 or related future pandemic. This research has the potential to make important contributions towards addressing some of the key public health problems in the U.S., including attainment of the UNAIDS 95-95-95 targets for HIV; addressing health disparities in the U.S.; and engendering health equity in public health interventions to address racial/ethnic disparities.